Task A77: Xenograft Mouse Models for Varicella Zoster Virus and Human Cytomegalovirus

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.